ISU VDL Ambient Ionization Equipment Proposal

2022 Vet-LIRN Grant for Ambient Ionization Equipment
Project Summary:
The purpose of this application is to purchase Coated Blade Spray (CBS) equipment for mass
spectrometry analysis. As analytical technologies improve it is essential for labs to have new
and improved analytical equipment. Coated Blade Spray mass spectrometry (CBS-MS) is an
approximately 8 year-old analytical technology that allows for the rapid analysis of several types
of samples in minutes. The Coated Blade Spray ionization source is interfaced directly with the
mass spectrometer and provides an ambient ionization platform for multiple sample types and
compounds. The time-consuming chromatography step of traditional liquid chromatography
mass spectrometry (LC-MS) analysis is eliminated with CBS-MS. The total analysis time for
samples with CBS-MS is under 2 minutes per sample. This new analytical technology would
greatly enhance the capacity of both the ISU VDL analytical laboratory and the Vet-LIRN
network.

Public health relevance
2021 Vet-LIRN Grant for Ambient Ionization Equipment Project Narrative Coated Blade Spray mass spectrometry is an ambient ionization technique for rapid detection and quantification of small molecules. This new technology allows labs to quickly respond to emergency situations. Rapid response in a diagnostic laboratory is essential for maintaining the integrity of products that effect human and animal health.